Rhythms of Resistance: Unraveling the impact of natural circadian variation on immunity

Project summary
The research program in our laboratory is centered on understanding how immunity and
defense are optimized. Using plants as model systems, we focus on how defense processes are
regulated by dynamic factors such as tissue type, development, ontogeny and importantly, the
interplay between circadian rhythms and immune responses. In this research program, we aim to
unravel how natural variations in circadian rhythms—referred to as chronotypes—influence the
timing and effectiveness of immune responses against a range of pathogens. This proposal will
exploit the natural variability in the genus Solanum to rapidly advance our understanding of how
circadian defense mechanisms have evolved as a function of different local environments.
Our work is built on the premise that, much like in humans, the circadian clock in plants
is a crucial regulator of immune function. Solanum species offer a rich diversity in circadian traits
that remain largely unexplored. Research from our lab shows that the timing of immune
optimization in Solanum differs from that of the classic model plant Arabidopsis, suggesting that
alternate regulatory mechanisms have evolved for this important trait. These findings indicate
that Solanum species have developed unique circadian adaptations to their environments,
optimizing their immune responses according to their specific chronotypes and environmental
cues. This diversity provides a valuable opportunity to deepen our understanding of how various
environmental factors, such as light, temperature, and humidity, influence biological rhythms and
circadian mediated immunity.
Our laboratory will leverage the genetic and phenotypic diversity within Solanum to
develop a powerful system to study these interactions and to identify key genetic variants and
regulatory networks that govern circadian-mediated immune responses. Using a multimethod
approach, including genome-wide association studies (GWAS), CRISPR gene editing,
transcriptomics, and epigenomics, we will elucidate the genetic and molecular mechanisms
underlying these processes. We will explore how these genetic differences translate into variations
in disease resistance, uncovering fundamental principles of how biological rhythms modulate
immunity. More importantly, the findings from our studies will advance our understanding of the
mechanisms by which circadian rhythms regulate immune function, offering potential parallels
to similar processes in humans. By shedding light on how timing influences immune responses
across different organisms, our work has significant implications for optimizing immune-related
treatments, improving vaccine efficacy, and understanding disease susceptibility in humans.

Public health relevance
Project Narrative This research aims to understand how natural variations in internal biological clocks, known as circadian rhythms, influence the timing and effectiveness of immune responses. Using plants as a model to understand these processes, we will gain insights into how similar variations in circadian rhythms may impact immunity in humans. This has the potential to lead to improved treatments for diseases and better strategies for maintaining health through the regulation of our own circadian rhythms.